FREEMIND: Focused Research Education and Experience using Multimodal and Interdisciplinary NIH Datasets

PROJECT SUMMARY/ABSTRACT
The overall objective of the R25 Focused Research Education and Experience using Multimodal and
Interdisciplinary NIH Datasets (FREEMIND) Program is to develop a diverse workforce in biomedical
research who will also be long-term users of datasets supported by the National Institutes of Health (NIH),
including NIH Common Fund datasets. The proposed program is designed to expand and diversify the pipeline
of new investigators in biomedical research. The program will include an intensive, two-week, in-person
bootcamp course at UC San Diego designed around providing hands-on instructional guidance for using data
from two Common Fund Programs, Bridge2AI and SPARC, as well as the NIH All of Us Research Program.
Jointly, these datasets provide a multimodal set of data (e.g. electronic health records [EHRs], imaging data,
waveform data, omics data) and offer great potential to train participants of the program in analyzing large
complex datasets across multiple disciplines (diabetes research, neuromodulation, biology, etc.). This program
will be led by an interdisciplinary team with a wide range of research expertise and a strong track record of
training, education, and mentorship. Participants will be graduate students, medical students, postdoctoral
fellows, and early career faculty (early stage investigators). They will engage in virtual didactic instruction both
before and after the bootcamp. The program includes a strong mentoring component, with faculty mentors
providing input on designing and executing projects using the NIH-supported datasets. During the bootcamp,
participants will complete projects in small groups and deliver oral presentations to discuss their results. The
educational program will include instruction on accessing and analyzing these datasets as well as in rigor and
reproducibility, responsible conduct of research, team science principles, and the practical aspects of
conducting large-scale, multi-disciplinary scientific collaborations. Innovations in this program include
leveraging real-life datasets, emphasizing multimodal analyses, and providing intensive guidance in a focused
format accessible to a broad array of participants, including clinician-scientists. The program will support
participants as they pursue publication and presentation opportunities to advance their careers. Broad
outreach will be conducted to enable diverse recruitment, and intensive program evaluation will be conducted
to facilitate iterative improvements to the syllabus and program administration. Program faculty include leaders
of the NIH-supported datasets being taught. By completing these aims, we will promote the broad and rigorous
use of Common Fund and other NIH-supported data among diverse participants in the formative stages of their
careers and help facilitate their advancement toward independent research careers and to becoming long-term
users of NIH datasets.

Public health relevance
PROJECT NARRATIVE There is a critical need for more individuals from diverse backgrounds to engage in biomedical research to solve complex human health challenges. This program aims to develop novel educational activities that encourage individuals from diverse backgrounds to pursue further studies or careers in biomedical research, specifically by developing hands-on instructional activities using datasets developed with the support of the National Institutes of Health (NIH). Through a combination of guidance for accessing and analyzing these datasets for mentored research projects, didactic activities, career development, and networking activities, this program will help advance participants' careers in biomedical research and prepare them to become long-term users of Common Fund and other NIH datasets.